Biomedical and Health Informatics Training Program

Project Summary The National Library of Medicine supports research training in biomedical informatics and data science at sixteen educational institutions in the United States. These training programs offer graduate education and postdoctoral research experiences in a wide range of areas including: health care informatics, translational bioinformatics, clinical research informatics, public health informatics. Each year an Informatics Training Conference is convened to bring NLM trainees together to showcase their work, to evaluate the full scope of current work in the field, and to meet their peers. Trainees appointed at the Veterans Administration (VA) sponsored training programs, NLM’s intramural trainees, and informatics trainees supported by BD2K T32 programs are also invited to attend and make presentations. This year, the 2021 Informatics Training Conference will be virtual due to the pandemic and will be hosted by the University of Washington (UW) June 21-23, 2021. The event will be held on a virtual platform using Zoom and will follow the typical course of a conference with plenary sessions, focus sessions, poster sessions, open mike sessions and some panel discussions. The Training Grant Directors will break away to meet and the NLM trainees will have an opportunity for social interaction via a virtual activity to support collegiality and academic experience. A student planning committee (SPC) has been formed with 2 representatives from the University of Washington and a representative trainee, (predoctoral or postdoctoral) from each of the NLM T15 sites. The SPC will be meeting to organize the agenda, review abstract submissions and plan a social activity for the conference attendees. Faculty and staff at the University of Washington began meeting in December 2020 with representatives from NLM and the Oregon Health Sciences University who hosted the event last year to gather information pertinent to planning a successful conference. UW faculty and staff continue to meet bi-weekly to plan logistics, create and launch the SPC, draft the agenda, issue the call for abstracts and to coordinate with UW’s Conference Services team to create a conference website, manage registration, and the creation of an eBook to include conference information including but not limited to the agenda, logistics and presenter abstracts.

Public health relevance
Project Narrative This year, the 2021 Informatics Training Conference will be virtual due to the pandemic and will be hosted by the University of Washington (UW) June 21-23, 2021. The event will be held on a virtual platform using Zoom and will follow the typical course of a conference with plenary sessions, focus sessions, poster sessions, open mike sessions and some panel discussions. The Training Grant Directors will break away to meet and the NLM trainees will have an opportunity for social interaction via a virtual activity to support collegiality and academic experience.